Role of Neuroprotective Indoles in Delaying the Onset of Cognitive Decline

PROJECT SUMMARY/ABSTRACT
This proposal is focused on an emerging hypothesis, developed by us, that age-related changes in the
level of certain neuroprotective molecules, produced by the microbiota, can influence the onset and/or rate of
progression of mild cognitive decline (MCI) due to Alzheimer’s disease (AD). We and others demonstrated that
small molecules related to indole substances, derived from intestinal bacteria, act systemically through diverse
pathways to promote cellular protection and reduce inflammation. Over two decades ago, we showed for the first
time, that some of these indoles have several beneficial effects on biological systems, including neuroprotection.
In addition, these substances have several properties that are important to AD therapeutics. 1) They are
neuroprotective; 2) They prevent the aggregation of amyloid into toxic forms and 3) They were shown (by others)
to have anti-inflammatory properties.
Studies from several independent investigators have confirmed and expanded our initial findings and
showed that bacteria-derived indoles extend lifespan and health-span of diverse organisms, including rotifers,
Drosophila melanogaster, and mice. It has been proposed that age-associated shifts in the microbiota
contributes to age-related infirmity, including the development of age-related neurodegenerative disease. The
identities of the bacterial molecules mediating multiple effects of the microbiota on the brain are not fully defined.
In humans, high serum levels of indole-3-propionic acid, for example, were tightly linked to a decreased incidence
of diabetes mellitus type 2. However, there is limited information available regarding the levels of these
substances and the onset of age-related neurodegenerative disorders such as MCI and AD.
Wide-scale profiling technologies, including metabolomics, open the door for novel discoveries related to
the pathogenesis of age-related neurodegenerative diseases. By applying metabolomics, we propose to
investigate whether the levels of these small molecules in the serum influence the age of onset and rates of
progression of MCI due to AD. Serum samples will be obtained at several time intervals during the active study
period. Our results will be supplemented and compared with samples from normal controls, subjects with MCI
(converters and non-converters) obtained two AD Centers with which we established collaborative
arrangements. Using a metabolomics approach and computerized algorithms, we will seek correlative
interactions between serum levels of neuroprotective indoles and the incidence of MCI as well as between these
and the rate of cognitive decline and brain atrophy, over time.
This is an exploratory set of projects, designed to obtain preliminary data for larger mechanistic studies
and therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Individuals with high serum levels of certain indoles, made by intestinal bacteria, show decreased risk for developing diabetes, cancer and other conditions; however, a potential relationship to neurological disease has not been investigated. This proposal will study if people with high circulating levels of certain indoles in the blood have a decrease risk for developing Alzheimer’s disease. If this proves to be the case, it may be possible develop these substances as diagnostic markers and therapeutic agents for Alzheimer’s disease.